Unraveling the Viral Infection Pathway with Virus-locked Observation

The development of single virus tracking (SVT) methods has given insight into previously
unresolved phases in viral infection. SVT methods have revealed critical steps in viral
internalization, envelope fusion, endocytic trafficking, and even virion assembly, but these
studies share a similar shortcoming. Current live-cell virus tracking methods can not probe deep
into samples and mainly capture dynamics near the coverslip surface, an interface foreign to the
cell that may not reflect actual in vivo behavior. Over the prior funding period, we
developed a powerful SVT microscopy technique for high-speed 3D tracking of single viruses.
This method, called 3D Tracking and Imaging (3D-TrIm), uses active feedback to lock on to the
real-time position of freely diffusing virions (up to 10 μm2/s) with high temporal resolution (down
to 10 μsec) deep within samples (axial ranges up to 50 μm). Critically, 3D-TrIm simultaneously
captures volumetric images of the cellular environment, placing these high-speed viral dynamics
in context. Using 3D-TrIm, we seek to delve far beyond the coverslip to perform single virus
tracking in the complex environments where viral infection truly occurs: the epithelia. The
epithelia, be it in the lung or the gastrointestinal tract, is a complex tissue with an extended
mucus layer and glycocalyx. These act as an important barrier to viral and bacterial infection
and are entirely missing in studies on simple cultured cells. Initial experiments will focus on how
the surface of cultured cells affects and inhibits the dynamics of freely diffusing VSV-G and
SARS-CoV-2 pseudotyped virus-like particles. High-speed 3D single virus tracking will then be
performed in real epithelial cultures to provide a first glimpse at the dynamics of single
viruses navigating through the viscous mucus layer and the size-excluding periciliary layer. The
proposed work will also probe how influenza A (IAV) uses a balance of receptor-binding
(hemagglutinin) and receptor-destroying (neuraminidase) envelope proteins to get through the
native epithelia. We will test the hypothesis that IAV acts as a "molecular walker" using a
Brownian ratchet mechanism to process through the epithelia. The validity of the "molecular
walker" model will be further probed by tracking HA- and NA-functionalized silver nanoparticles
with nm spatial and μsec temporal resolution to look for processivity along sialic acid residues.
Finally, we aim to advance 3D-TrIm towards tracking in more complex tissue environments.
Tracking in highly scattering and highly autofluorescent tissues will be accomplished with
recursive Bayesian filtering and information-efficient sampling to distinguish photons from
tracked particles versus background photons. The studies proposed herein will be the first to
probe viral dynamics in the complex epithelia. The dynamics of the tracked viral particles will
yield critical insight into the mechanism of viral infection through a host organism's first line of
defense and provide guidelines on designing successful therapeutics for crossing the epithelial
barrier. In this supplement, we will replace a critical laser unit which will not only enable the aims
above, but open the possibility for a label-free, stimulated Raman scattering-based approach
that will extend high-speed SVT into organoids and primary tissue culture.

Public health relevance
Methods for evaluating the fate of single virions have led to a wealth of information on disease states but have been primarily limited to surface studies and artificial culture environments. This work will develop and apply high-speed 3D single-virus tracking methods to capture how viruses such as influenza and SARS-CoV-2 navigate the complex epithelial space. Outcomes from this work will shed light on the mechanisms through which virions traverse the first line of defense of the human immune system.